Columbia University Science of Behavior Change Resource and Coordinating Center renewal - administrative supplement

Project Summary/Abstract
This overall goal of this administrative supplement to the Columbia University Science of Behavior Change
(SOBC) Resource and Coordinating Center (RCC) is to disseminate mechanistic behavioral science to leaders in
behavioral medicine through collaboration with the Academy of Behavioral Medicine Research (ABMR). The
primary approach to accomplishing this goal will be to infuse SOBC content into ABMR’s annual meetings and
to support ABMR’s Early-Stage Investigator (ESI) program. The ESI program is designed to facilitate the
success of a diverse group of exceptional early career investigators (at least 50% from underrepresented
groups) who are entering the field of mechanistic behavioral science. The program provides awardees with an
unprecedented opportunity to participate in the ABMR meeting, learn about SOBC’s experimental medicine
approach, network with senior scholars in the field, and participate in a leadership development and career
development workshop. The supplement will also support the integration of SOBC content into the annual
meeting programming and the engagement of ESIs in SOBC RCC working groups after the meeting. The
mission of ABMR is to provide a forum for established scientists and thought leaders working in the
transdisciplinary field of behavioral science to exchange cutting-edge ideas in an informal, yet scientifically
charged atmosphere. Its members are distinguished basic and applied scientists elected by peers for
outstanding contributions to the field. In alignment with NIMHD’s Health Disparities Framework and NIH’s
UNITE initiative, the theme of the 2022 meeting is “Healthy Aging across the Lifespan: The impact of
Socioeconomic Status.” The objective of this meeting is to provide a cutting-edge examination of multifactorial
and preventable determinants of health inequities, as well as focus on modifiable and mechanistic pathways
linking these determinants to lifelong health processes and outcomes. The 2023 meeting will examine why
behavioral interventions are not being systematically implemented into clinical practice and how the SOBC
approach can help. The aims of this supplement are aligned with the goals of the RCC, which include (1)
serving as a hub for scientists to evaluate, discuss, and disseminate mechanisms-focused behavioral science;
(2) engaging with national scientific organizations and bringing basic and applied/clinical scientists together to
promote collaborations and further advances in mechanistic behavioral science; and (3) conducting outreach
and dissemination of the experimental medicine approach. Specific aims of the supplement are to: (1) Expose
diverse ESIs to the SOBC approach through participation in the ABMR meeting; (2) To provide
leadership and career development training for diverse ESI Fellows; and (3) To introduce early
and senior career leaders in behavioral medicine to critical topics in behavioral mechanistic
science.

Public health relevance
Project Narrative This goal of this administrative supplement to the Columbia University Science of Behavioral Change (SOBC) Resource and Coordinating Center (RCC) is to disseminate the SOBC experimental medicine approach through collaboration with the Academy of Behavioral Medicine Research (ABMR). The award will sponsor the participation of a diverse group of eleven early-stage investigators (ESIs) in the 2022 and 2023 ABMR annual scientific meetings; fund a leadership training and career mentoring program that will take place during and after the ABMR meeting; and support the infusion of SOBC content to leaders in behavioral medicine throughout the ABMR meeting. This award will advance the goals of the RCC by further advancing mechanistic behavioral science and widely disseminating the experimental medicine approach.